Genomic signatures of primate-pathogen interactions

PROJECT SUMMARY
Population genomic data carry a detailed record of evolutionary history, but this record is simultaneously
impacted by multiple evolutionary forces making interpretation extremely challenging. Methods development
and increasing accessibility of large-scale genomic datasets have led to more powerful strategies to
disentangle the effects of natural selection and identify loci underlying recent adaptation. Yet we still lack
understanding of many aspects of adaptive processes, including the types of genetic variation (e.g., point
mutations vs. structural variants), numbers of loci, and selective regimes by which it occurs. Over the next five
years, research in the Leffler lab aims to probe the genetics of adaptation by developing new approaches and
datasets to study loci under recent pathogen-driven selective pressures in humans and non-human primates.
Pathogens have a severe impact on host fitness and survival and consequently are a driving force for
evolutionary change and an effective model system for learning about selective processes. We will combine
approaches in computational, population and evolutionary genomics to explore a range of signatures that host-
pathogen interactions leave in our genomes, organized in three project areas. First, we will characterize
population genomic variation in the Arabian Peninsula, developing a new sequence-based approach to identify
adaptive gene flow post-admixture and test for enrichment related to infectious disease, particularly focusing
on blood group variation. Second, we will analyze copy number variation in paralogous gene clusters,
developing new methods for inference of both copy number and selection, in order to test whether they may be
frequent targets of pathogen-driven selection. Finally, we will investigate evolutionary genomics of wild
macaques in southeast Asia. We will assess evidence for pathogen-driven selection by comparing allele
frequencies in populations with a range of pathogen burdens and different levels of admixture with closely
related species living in the absence of these pathogens. Together, the results of these research projects will
provide new tools, datasets, and significant insight into the impact of host-pathogen co-evolution across
populations, gene families, and primate species.

Public health relevance
PROJECT NARRATIVE Pathogens directly impact individual survival and thus strongly influence the genetics of host populations, providing a model for studying evolutionary processes of adaptation. In this proposal, we investigate the impact of host-pathogen interactions on human and non-human primate genomes focusing on admixed human and non-human primate populations and copy number variation. This work will reveal new patterns of natural selection and phenotypic associations at genes involved in recent battles against infectious pathogens.